EDUCATIONAL MATERIALS THAT SHOWCASE CONCEPTS FOR MAPPING STATISTICAL ESTIMATES WITH RELIABILITY INFORMATION

EDUCATIONAL MATERIALS THAT SHOWCASE CONCEPTS FOR MAPPING STATISTICAL ESTIMATES WITH RELIABILITY INFORMATION IN SUPPORT OF THE NATIONAL CANCER INSTITUTE